Core--Microscopy and Imaging

Two research technicians are requested; their primary role will be to train individuals to use the core facility, oversee the use and care of equipment, and perform immunolabeling and in situ hybridization procedures. Funds are requested to purchase a research microscope, camera, computers and software, and a thermal color printer.